Corticothalamic network function in chronic pain

PROJECT SUMMARY
This study focuses on understanding the complex nature of chronic pain by investigating the communication
between distinct brain circuits. We aim to unravel the mechanisms by which somatosensory, cognitive, and
affective information is integrated to produce the percept of pain. By studying network dynamics across key brain
regions using direct intracranial recordings and graph theory approaches, we will elucidate spatiotemporal
activity patterns that underlie the affective and cognitive dimensions of pain. Previous studies have identified
specific brain regions, such as the anterior cingulate cortex (ACC), medial prefrontal cortex (mPFC), insula,
sensory and medial thalamus, periventricular grey matter, and primary sensorimotor cortices, as crucial hubs
involved in regulating chronic pain traits. However, the dynamic functioning of these networks in influencing the
fluctuating nature of chronic pain, which can vary over minutes to days, remains less understood. To bridge this
knowledge gap, the study proposes the use of direct intracranial recordings from patients with chronic pain and
combines them with graph theory approaches to analyze network dynamics. We aim to study pain circuits in the
laboratory and naturalistic environments by investigating the impact of expectation and mood on descending
circuits and determining if they influence pain through similar mechanisms. The hypothesis is that brain
stimulation relieving pain engages descending control mechanisms similar to positive mood or expectation, while
a breakdown in corticothalamic functional connectivity is associated with episodes of elevated pain. The study
proposes three specific aims. Aim 1 involves analyzing intracranial recordings from chronic pain patients to track
changes in functional connectivity within corticothalamic networks during spontaneous pain and pain-relieving
brain stimulation. Aim 2 focuses on examining the interaction between ascending and descending circuits during
a cognitive pain-expectation task using recordings from patients with DBS electrodes. Aim 3 investigates the role
of affective state on pain perception and descending pain circuits during a mood modulating task. Our group
aims to identify patterns of functional connectivity and coherence between key brain hubs, such as the ACC,
medial prefrontal cortex, insula, and thalamus, and understand their relationship with pain perception. By
clarifying the underlying mechanisms of chronic pain and the effects of brain stimulation, mood, and expectation,
this study has the potential to contribute to the development of novel diagnostic tools and more effective
treatments for chronic pain disorders.

Public health relevance
PROJECT NARRATIVE This study aims to investigate how top-down brain networks influence pain processing using direct intracranial brain recordings during chronic pain and pain relief. It will explore the interaction between ascending and descending circuits and examine the influence of emotion and expectation on pain perception. The findings will contribute to understanding the underlying mechanisms of chronic pain and may inform new approaches for pain diagnosis and treatment.